Immune regulation of intestinal health and disease

PROJECT ABSTRACT
The gastrointestinal tract is colonized with trillions of normally beneficial microbes, termed the microbiota, that
are essential for human health. However, the pathogenesis of numerous infectious, inflammatory, and
metabolic diseases involves a loss of immunologic tolerance to the gut microbiota. This has been
demonstrated robustly in basic, translational, and clinical studies of inflammatory bowel disease (IBD). The
fundamental focus of our proposed renewal for R01AI123368 is to build on recent paradigm-shifting
results from the first funding cycle that detailed a novel pathway that is essential to orchestrate
immune tolerance to gut microbiota and restrain intestinal inflammation. Specifically, our prior studies
detailed how group 3 innate lymphoid cells (ILC3s) present microbiota-derived antigens to CD4 T cells on
MHCII, instruct the differentiation of a unique form of RORgt+ regulatory T cells (Tregs), and prevent
spontaneous intestinal inflammation. Further, we find that these cellular interactions are dysregulated in the
inflamed intestine of individuals with IBD (see Zhou et al., Nature, 2022 and Lyu et al., Nature, 2022 as the
most recent examples). We generated new preliminary data to support this renewal application where we
propose to mechanistically advance this paradigm and will explore the therapeutic potential of our key findings.
This includes three specific aims, which will: (i) define how ILC3s sense microbiota to initiative antigen
presentation, (ii) elucidate key molecular determinants endowing a tolerogenic program in MHCII+ ILC3s, and
(iii) identify whether MHCII+ ILC3s can be harnessed to enforce tolerance to diverse microbes or restrain gut
inflammation as a pre-clinical therapy. We will employ basic mouse models, as well as translate our findings
into human specimens. This research is directly relevant to IBD and many other chronic inflammatory diseases
where disruptions to immune tolerance underlie disease pathogenesis, and it is expected that our mechanistic
results will provoke new opportunities for preventative, therapeutic or curative treatment strategies.

Public health relevance
PROJECT NARRATIVE Inflammatory bowel disease (IBD) is a chronic immune-mediated disease that impacts over 3 million Americans, represents a major socio-economic health challenge, and currently has limited preventative, therapeutic or curative treatment strategies. Basic, translational, and clinical studies defined that the pathogenesis of IBD is mediated by a loss of immunologic tolerance to beneficial microbes colonizing the intestine termed microbiota. The focus of this proposal is to delineate a novel pathway that is essential to orchestrate immune tolerance to gut microbiota and restrain intestinal inflammation, as well as explore the pre- clinical therapeutic potential of our findings.